Sperm chromatin structure and remodeling during spermiogenesis and fertilization

PROJECT SUMMARY
Genetic inheritance material of a eukaryotic organism (DNA) is stored in chromosomes. Understanding
of cellular activities in normal development and disease requires the analyses of critical regulatory roles that
are played by packaging the genome into a nucleoprotein complex termed chromatin. The structure of
chromatin and the regulatory machinery of its metabolism are uniquely important and thus, strongly
conserved in evolution.
The objective of our work is to understand the relationship between the establishment of chromatin
structure in the male gametes (sperm cells) and regulation of their function. We will focus on a systematic
study of sperm chromatin structure and factors that mediate its assembly and remodeling during
spermiogenesis and egg fertilization in a model organism, fruit fly (Drosophila melanogaster). Sperm
chromatin differs in composition and architecture from the normal cell chromatin, in particular by an
extraordinary high degree of DNA condensation. It is rigid, enzymatically static and is formed by compaction
of the DNA with small cysteine-rich proteins termed protamines (and other sperm nuclear basic proteins,
SNBPs). Despite its importance for the life cycle of any sexually reproducing organism, sperm chromatin
structure has been poorly studied. To fill this gap, we will perform biochemical, biophysical and structural
analyses of in vitro reconstituted Drosophila sperm chromatin.
Sperm chromatin replaces that of somatic cells and is assembled/remodeled in multiple steps during
sperm differentiation (spermiogenesis). At fertilization, the egg also faces the challenge of remodeling the
condensed sperm chromatin into an accessible, transcription- and replication-competent form. We recently
discovered cellular machinery that mediates sperm chromatin remodeling (SCR) in vitro and in vivo. Thus,
we will study the factors (protamine chaperones and enzymes of the thioredoxin system) that mediate SCR.
Protamines in sperm undergo cysteine oxidation and oligomerization via intra- and inter-molecular
disulfide bonds. For fertilization success, the disulfides have to be reduced by egg-specific thioredoxins. Thus,
we will evaluate small-molecule inhibitors of the thioredoxin system as candidate agents to manipulate fly and
mouse fertility (putative contraceptive drugs).
The successful completion of this project will lead to a comprehensive biochemical and biological
characterization of factors that mediate the assembly and remodeling of metazoan sperm chromatin. More
globally, our work will provide insights into the role of chromosome assembly and maintenance in regulation
of the cell function and will be applicable to understanding, diagnosis and treatment of human conditions that
involve defects in chromatin structure.

Public health relevance
NARRATIVE In human and animal cells, DNA is condensed in a nucleoprotein complex termed chromatin that is essential for the maintenance of genome integrity and regulation of cellular functions. The goal of this project is to understand the chromatin structure in sperm cells and the function of protein factors that mediate its assembly and remodeling. Our work will help to design methods of diagnosis and treatment of human conditions that involve defects in sperm chromatin metabolism, such as infertility, as well as novel approaches to contraception.